PKU Now-Connect: An intelligent digital ecosystem to improve health outcomes in Phenylketonuria

Abstract
Phenylketonuria (PKU) is an inherited genetic disorder that results in an inability to metabolize the essential
amino acid phenylalanine (Phe). Consequences of uncontrolled blood Phe include intellectual disabilities,
seizures, skin disorders, tremors, hyperactivity, EEG abnormalities, behavioral problems, executive dysfunction,
and psychiatric disorders. PKU affects approximately 1 in 24,000 people and an estimated 450,000 individuals
worldwide. In the United States, PKU occurs in 1 out of every 10,000 newborns. PKU patients are recommended
to maintain blood Phe levels within 2-6 mg/dL (121-363 µmol/L). This requires a combination of specialized diet,
medication, and clinic visits. It is a significant challenge for patients to manage their blood Phe levels due mainly
to the lack of real-time feedback on blood Phe levels. The purpose of this Phase I SBIR application is to develop
and demonstrate the feasibility of a remote monitoring platform for PKU management centered around an
existing point-of-care (POC) device. The PKU Now-Connect will be comprised of a POC meter for measuring
blood Phe concentrations, a paired mobile app for displaying results and tracking Phe intake, and an interactive
web dashboard with connectivity to experts, dietitians, or healthcare providers. The specific aims for this
application are: 1) Finalize the PKU Now Mobile App, 2) Design and Integrate Web Dashboard with Mobile App,
and 3) User Experience and Platform Usability Tests. An existing POC meter (previous Phase II award, Project
Grant R44GM126593) and prototype mobile app will be used as a base template. In Phase I, a user-friendly
mobile app will be designed and tested for tracking Phe intake and blood Phe levels via the POC meter. Next, a
database and web dashboard for storing, displaying, and transforming data will be designed, tested, and
implemented to a cloud server. Finally, recruited subjects will be asked to use the PKU Now-Connect to assess
the user experience and usability of the platform. Expert opinions from the Children’s Hospital of Chicago, the
Phenylalanine Families and Researchers Exploring Evidence (PHEFREE) Consortium, and the National PKU
Alliance (NPKUA) will be obtained. In Phase II, clinical studies in collaboration with Boston Children’s Hospital
and University of Pittsburgh Medical Center will be completed to validate the feasibility of the PKU Now-Connect
in a clinical setting with PKU patients. The database will be expanded to include secured patient information,
expanded tracking of medication and symptoms, and direct communication with healthcare providers. If the
platform is successful, FDA Guidance “Content of Premarket Submission for Device Software Functions” issued
Nov. 4, 2021, and “Policy for Device Software Functions for Mobile and Medical Applications” issued Sept. 27,
2019, will be followed for 510 K submission. The PKU Now-Connect will have a significant, positive impact on
PKU patients and their caregivers.

Public health relevance
Narrative: There is an urgent, unmet need for a remote monitoring platform for individuals with phenylketonuria (PKU), a disorder characterized by uncontrolled phenylalanine (Phe) in the blood. The PKU Now-Connect is an intelligent digital ecosystem driven by smart workflows, data visualization, and communication with healthcare providers to track and manage blood Phe levels. The ability to track blood Phe in real-time and disseminate this data to healthcare providers will have a significant, positive impact on the PKU community with the potential to impact all inborn errors of metabolism.